Connecting Neuronal Hyperexcitability and Sex Differences in Alzheimer's Disease (AD) using biophysically-informed in-silico brain simulations and experimental data from mouse models of AD

The mechanism underlying neuronal hyperexcitability, as a result of excitation-inhibition (E-I) imbalance, leading
to cognitive deterioration in Alzheimer’s disease (AD) is not fully understood and effective approaches to prevent
or reverse memory deficits are unavailable. Our multimodal MRI connectomics demonstrated a hyperexcitation
connectome phenotype in healthy women ApoE4 carriers as they age, raising the possibility that at least some
sex differences in AD may be explained by E4 female carrier-specific neuronal hyperexcitation. In support of
this, resting state functional magnetic resonance imaging (rs-fMRI) in APPNL-G-F/NL-G-F revealed higher
interhemispheric functional connectivity in the hippocampus of female mid-life mice. Further, we observed
reduced functional anisotropy, altered myelin and oligodendrocyte count, and importantly, altered transcription
phenotype of excitatory and inhibitory neurons in the hippocampus of these female mice. The antiseizure drug
Levetiracetam (LEV) is currently being tested in human trials, with early data suggesting that it does improve
cognition in those with signs of hyperexcitability. However, there is conflicting information concerning the efficacy
of the drug and its mechanism is not fully understood. This collaborative, multidisciplinary MPI program is aimed
at unraveling the efficacy of LEV in humans and mouse models by leveraging expertise in computational and
experimental neuroscience. We will test the hypothesis that hyperexcitability is more prevalent both in ApoE4
woman carriers and in female FAD-linked APPNL-G-F/NL-G-F and LOAD-linked ApoE4 knockin mice and that
LEV treatment will normalize hyperexcitability and cognitive deficits in a sex-dependent manner. In the
R21 Phase, the experimental approach will establish feasibility of LEV treatment in APPNL-G-F/NL-G-F female mice.
The computational approach will develop new biophysically - informed computational framework for modeling
experimental mouse data. In the R33 Phase, we will establish the effect of LEV on hyperexcitability and pathology
in association with sex, ApoE4 and amyloidosis, and generalize our computational approaches from mouse
hippocampus to the entire brain to characterize the whole-brain biophysical parameters of E-I balance in AD with
or without LEV treatment. The results of this program will provide novel insight into the molecular mechanism of
E-I and LEV, and its therapeutic value in AD.

Public health relevance
Project Narrative This multidisciplinary MPI program will use in silico computational and in vivo experimental approaches to study the molecular, cellular and circuit mechanisms of sex-, ApoE- and amyloidosis- dependent hyperexcitability in humans and animal models of Alzheimer’s disease and the therapeutic efficacy of the antiseizure drug Levetiracetam.